MIND Institute Intellectual and Developmental Disabilities Research Center

ORIGINAL PROJECT SUMMARY – OVERALL PARENT AWARD
The present application seeks funding to continue the MIND Institute Intellectual and Developmental
Disabilities Research Center (IDDRC) at the University of California, Davis. The IDDRC was launched in 2013
and is the newest of the 14 IDDRCs in the network. The MIND Institute IDDRC will address four specific aims.
Aim 1 is to conduct interdisciplinary translational research that yields insights into the nature, causes, and
consequences of IDD and leads to innovative evidence-based approaches to prevention and treatment. To this
end, we propose 81 externally funded projects that reflect the themes of Integrated Biobehavioral
Characterization of IDD, Genetic and Environmental Contributions to IDD, and Treatment of IDD. These projects
are led by 43 investigators from 16 academic departments and 5 schools/colleges. 68 projects are funded by the
NIH, including 16 by NICHD. Aim 2 is to accelerate the pace of interdisciplinary translational research via the
operation of cost-effective, innovative, and widely used scientific cores. In addition to an Administrative Core, we
propose four scientific cores. The Clinical Translational Core will facilitate recruitment of various populations of
human participants, provide specialized clinical expertise to diagnose and characterize participants, support
complex phenotyping, collect and store biospecimens, and integrate digital technologies into treatment studies.
The Biological and Molecular Analysis Core will provide access to expertise and technologies in the areas of
immune function, cellular and molecular imaging, epigenetics, and environmental exposures as they relate to
neural development. The Rodent Behavior Core will provide assays of mouse and rat behavior, guidance in the
development of mutant rodent models, and support for preclinical evaluations of drug safety and efficacy. The
Biostatistics, Bioinformatics, and Research Design Core will provide support for study design, creation of
electronic data capture and management systems, and statistical analysis of complex multidimensional datasets.
Aim 3 is to improve the lives of people with IDD and reduce health and social discrepancies in care by developing
a robust plan for disseminating and implementing scientific discoveries. The plan will involve multiple paths of
communication to target professionals and policy makers, reach numerous communities, while being informed
by the perspectives of people with IDD and their families. Aim 4 is to conduct a signature research project that
examines the heterogeneity of outcomes and mechanisms underlying those outcomes in maternal autoantibody
related (MAR) autism spectrum disorder (ASD), which may account for as much as 20% of ASD cases. The
project will make use of existing human clinical data to inform the creation of rat model systems to test
hypotheses about causal mechanisms. The signature project addresses three RFA themes: Preventing and
mitigating the impact of exposures that can cause IDD, Outcome measures or biomarkers for interventions or
treatments, and Development of biomarkers or assessment measures in more than one IDD condition.

Public health relevance
PROJECT NARRATIVE The UC Davis IDDRC supports a translational science agenda focused on intellectual and developmental disabilities (IDDs). The IDDRC integrates research from multiple disciplines and bridges basic and clinical science with the support of dynamic and cutting-edge scientific cores to arrive at treatments for IDDs. The IDDRC’s partnerships locally and nationally, and robust dissemination plan ensure its discoveries improve the lives of individuals with IDD and their families.